The Lymphatic Forum 2021

Summary/Abstract:
The Lymphatic Forum 2021 (LF2021) will be the 3rd iteration of a planned conference series that bring
together researchers from around the world that study lymphatics in health and disease. The lymphatic
system is a relatively understudied, yet vital component of the cardiovascular system that couples the tissue
parenchyma to the venous blood via lymph flow through a complex network of lymphatic vessels. It transports
fluid, macromolecules, lipids, tissue catabolic products and immune cells/agents as lymph. Thus, the
lymphatic system provides critical links for the transport of fluid, macromolecules, cells and other elements
from the interstitial space of all organs to and through numerous lymph nodes to the venous blood. In
completing this transport, it regulates body fluid volume, macromolecular homeostasis, immune function,
inflammation and lipid absorption/metabolism. It is a specialized vascular system with a complex network of
low-pressure vessels with unique mechanisms to form and transport lymph. The lymphatic system serves
as both a complex network of lymph conduits and as a series of unique intrinsic lymph pumps that generate
and regulate the lymph flow that drives all of its functions. Because of its unique, complex structural and
functional characteristics, it has been difficult to examine and quantify its structure and function in the body.
However, a better understanding of its structure and function is important to health and disease. Other
international/national lymphatic biology conferences, including the previous Lymphatic Forum 2017 and
2019 focused predominantly on the embryologic development, lymphangiogenesis, lymphatic endothelial
cell function and relationships to cancer and immunity. The conference plan outlined in this application is
unique in that it is the first to address the significant role and functions of the lymphatic vascular system in
the various organs of the human body. Accordingly, the Forum’s program is designed to pay particular
attention to the complex aspects of the lymphatic vascular system in the normal function of, and pathologies
associated with, these organs. Presentations and discussions will focus on the molecular regulation of
lymphatic development in a specific organ, the description of organ diseases and the known or suggested
lymphatic dysfunctions and/or immune dysregulations in that organ that could explain or contribute to the
disease and its development. The lymphatic system is an intrinsic, understudied part of the cardiovascular
and the immune systems that influences health and disease. The goal of LF2021 is thus highly relevant to
the missions of the NHLBI which has accepted primary assignment on this application, but also of the
NIDDK and the NIAID, which will be asked for secondary support. Additionally, the conference is specifically
designed such that trainees and young investigators have significant roles.

Public health relevance
Narrative: The Lymphatic Forum 2021 is the 3rd iteration of a planned conference series that bring together established and young researchers from around the world that study lymphatics in health and disease. The lymphatic vascular system is a relatively understudied, yet vital component of the cardiovascular system that couples the tissue parenchyma to the blood via lymph flow through a complex vascular network. The conference plan pays particular attention to young investigators and focuses on complex aspects of the lymphatic system such as biomechanics of lymphatic structure and function, lymphatic development, growth and remodeling, mechanisms of lymph flow generation and regulation as they apply to bodily organs and their functions, and the relationships between the lymphatic and immune systems and inflammation regulations as it pertains to pathologies associated with these specific organs.